Genomic Analysis of Inherited Breast and Ovarian Cancer

The discovery of BRCA1 and BRCA2 and other genes of homologous recombination repair, and the
characterization of the roles of these genes in inherited predisposition to breast and ovarian cancer, have had a
tremendous impact on cancer prevention and treatment. Yet family history remains one of the most important
risk factors for these cancers, and a great deal of that risk remains unexplained. We propose two hypotheses.:
(1) In some families, breast cancer is due to previously cryptic non-coding variation altering transcription and/or
expression of known breast cancer genes (BRCA1, BRCA2, PALB2, ATM, CHEK2, BARD1, BRIP1, RAD51C,
RAD51D, and TP53); and (2) In some families, breast cancer is due to rare or private non-coding variants
regulating expression of critical genes with no cancer-predisposing alleles in coding sequence.
To test these hypotheses, we will deploy new technologies: long-read sequencing of genomic and cDNA; Fiber-
seq identification of regions of open chromatin in cell types of choice; massively parallel reporter assays (MPRA)
to compare effects of variant versus reference alleles for many sites simultaneously; and CRISPR inhibition
(CRISPRi) of candidate regulatory regions. We propose to integrate these approaches to discover and
characterize classes of non-coding pathogenic variation in 1253 extended families, severely affected with breast
and/or ovarian cancer, but for whom no causal variants have been found by any current genomic technology.
In Aim 1, we will use adaptive-sampling long-read genomic sequencing to determine the spectrum of all classes
of rare non-coding variants in the extended TADs of the known breast cancer genes. In Aim 2. we will use long-
read cDNA sequencing to characterize transcriptional consequences of the complex SVs and rare deep intronic
SNVs co-segregating with breast cancer (from Aim 1). In Aim 3, we will use Fiber-seq analyses (already in hand)
of fallopian tube epithelial cells and MCF10A mammary cells to identify candidate regulatory regions of breast
cancer genes. Then, for rare variants in these peaks that are co-inherited with breast cancer in unsolved families,
we will use MPRA to test allele-specific differences in reporter activity; and in parallel silence the regions with
CRISPRi to evaluate their effects on gene expression. In Aim 4, we will extend Aim 3 genome-wide, to identify
variants near other breast cancer-relevant genes that lie in open chromatin regions, that co-segregate with breast
cancer in unsolved families, and that reveal allele-specific differences in regulatory activity.
We expect to discover clinically meaningful genetic variation in non-coding regulatory regions, including in
repetitive genomic neighborhoods particularly subject to complex rearrangement. We expect that this approach
will be directly applicable to any complex diseases with an inherited genetic influence.

Public health relevance
The discovery and characterization of BRCA1 and BRCA2 and their sister genes have had tremendous impact on prevention and treatment of breast and ovarian cancer, yet family history remains one of the most important risk factors for these cancers, and a great deal of that risk remains unexplained as the result of technical limitations of current genomics technologies. The goal of this project is to deploy transformative new technologies on behalf of these families. This project is intended to stimulate discovery of causal genetic events for inherited breast and ovarian cancer and thereby for other inherited illnesses.